Clonal hematopoiesis as a mediator of cardiovascular disease in women with premature menopause

PROJECT SUMMARY / ABSTRACT
This NIH Mentored Clinical Scientist Research Career Development Award (K08) proposal describes a five-
year training program for mentored career development in academic cardiovascular medicine. The principal
investigator, Dr. Michael Honigberg, is a staff cardiologist at Massachusetts General Hospital (MGH), an
Instructor of Medicine at Harvard Medical School, and a prior trainee of the NHLBI-sponsored T32 training
grant at Brigham and Women’s Hospital. The primary goal of this award is for the candidate to obtain the
training and skills necessary to become a successful independent physician-scientist. His long-term career
goal is to use multi-omics approaches to elucidate disease mechanisms and discover novel targets for the
prevention and treatment of heart disease, with a focus on cardiovascular disease (CVD) in women.
Clonal hematopoiesis of indeterminate potential (CHIP) refers to the expansion of blood stem cells harboring
acquired mutations in leukemia-associated genes. CHIP predisposes to accelerated atherosclerosis. In Dr.
Honigberg’s preliminary work, he showed that women with a history of premature menopause are enriched for
CHIP by 1.4-fold and that CHIP is independently associated with incident CVD in postmenopausal women. He
now proposes to test the hypothesis that CHIP is a key mediator of accelerated CVD in women with premature
age of menopause using multiple complementary approaches. In Aim 1, he will associate age at menopause
with expansion of CHIP clones over time and incident CVD in cohorts with serial next-generation sequencing.
In Aim 2, he will use large proteomic datasets to discover and validate novel protein biomarkers of CHIP and
test the role of these proteins in premature menopause-associated CVD. In Aim 3, he will use machine
learning approaches to train, validate, and test a CHIP risk classifier to guide CHIP screening in women.
The proposed training plan involves primary mentorship from Dr. Pradeep Natarajan, an expert in genomics
and atherosclerotic CVD prevention, and co-mentorship from Dr. JoAnn Manson, principal investigator of the
Women’s Health Initiative and an expert in menopause, sex hormones, and CVD in women. Both mentors are
enthusiastic about supporting Dr. Honigberg’s career development. The training plan additionally involves a
distinguished Scientific Advisory Committee including experts in proteomics and multi-omics investigation (Dr.
Robert Gerszten, Beth Israel Deaconess Medical Center), clonal hematopoiesis and myeloid malignancy (Dr.
Benjamin Ebert, Dana-Farber Cancer Institute), inflammation and vascular biology (Dr. Peter Libby, Brigham
and Women’s Hospital), and machine learning (Dr. Puneet Batra, Broad Institute of MIT and Harvard). The
candidate will leverage coursework, facilities, and resources from across MGH, Harvard University, MIT, and
the Broad Institute toward completion of his proposed training and research plan. Dr. Honigberg’s structured
training plan will develop the skills necessary to pursue a research program distinct from that of his mentors
and will facilitate his transition to an independent, R01-funded physician-scientist.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE Cardiovascular disease (CVD) is the leading killer of women in the United States and worldwide, and women with premature age of menopause have elevated risk of developing CVD for unclear reasons. Preliminary data suggest women with premature menopause have increased risk of CHIP, a recently recognized asymptomatic blood condition associated with accelerated development of CVD and adverse CVD outcomes. The proposed study will investigate whether CHIP is responsible for CVD in women with premature menopause and will identify new targets for the prevention and treatment of premature menopause-associated CVD.